Prevention of auditory nerve degeneration in noise-induced hearing loss

Hearing loss due to excessive noise exposure is one of the most common military service-connected
disabilities. This neurosensory disorder significantly impacts communication abilities, daily duty performance,
and quality of life of Veterans. For example, more than 1.3 million Veterans received disability compensation
for hearing loss in 2020. Hearing loss also shares significant comorbidity with traumatic brain injury,
posttraumatic stress disorder, and depression. Currently, there are no FDA-approved medications for
preventing noise-induced hearing loss (NIHL); therefore, investigations are urgently needed to uncover new
cellular and molecular mechanisms of NIHL and develop efficient pre-clinical treatment strategies for this
common communication disorder.
To begin to address this important public health concern, we have investigated the roles of
dysmyelination and dysregulation of Quaking (QKI) RNA binding proteins (RBPs) in auditory nerve (AN)
degeneration and functional decline following noise injury. The AN is the primary conveyor of acoustic
information from sensory hair cells to the brainstem. Approximately 95% of AN fibers are myelinated by glial
cells. Noise exposure experienced by service members can lead to loss and/or dysfunction of multiple cell
types in the peripheral auditory system, including glial cells of the AN. Glial cell dysfunction occurs immediately
after excessive noise exposure and results in demyelination, and alterations in glial-associated paranodal
structures at the node of Ranvier, which leads to AN degeneration and auditory function impairment. Our
recent study revealed that the integrity of myelin and two types of paranodal structures associated with
Schwann and satellite cells is critical for the maintenance of normal AN function. A QKI deficiency in adult
mouse glial cells results in loss of myelin, deterioration of paranodal structures, AN dysfunction, and hearing
loss. QKI RBP isoforms (including three alternative splicing isoforms QKI-5, QKI-5, and QKI-7) are
differentially expressed in mouse Schwann and satellite cells during AN development and myelination.
Excessive noise exposure is associated with an upregulation of QKI-7, but not QKI-5 and QKI-6, which may
contribute to demyelination (or a fail in remyelination) and AN functional declines. Together, these exciting new
observations strongly suggest that QKI RBPs are critical regulators of myelin formation and maintenance in the
AN. We hypothesize that manipulation of QKI isoform expression (and their downstream targets) in cochlear
glial cells will affect AN maintenance, repair of myelin structures and improvement of auditory function after
noise injury. To test this hypothesis, Aim 1 will determine how dysregulation of QKI RBP expression leads to
downstream changes that result in demyelination, disruption of nodes of Ranvier and AN degeneration
following excessive noise exposure. We will also determine if key QKI targets identified in animal models are
present in human AN glial cells using human temporal bones. Aim 2 will determine the extent to which
manipulation of expression levels of QKI isoforms and/or key QKI targets can preserve myelin structure and
reduce AN degeneration after noise injury. Using well-established animal models and human cochlear tissues,
knowledge gained from this translational study will further substantiate the use of QKI RBPs as key therapeutic
targets to alleviate noise-induced hearing loss in Veterans.

Public health relevance
Hearing loss, often the result of exposure to excessive noise during military service, is the most common service-connected disability among American Veterans, affecting communication abilities and quality of life. Hearing involves the reception of sound through the inner ear and transmission to the brain via auditory nerve fibers that are covered with an insulating layer called myelin. Glial cells are a specialized cell type in the auditory nerve that generates and maintains myelin, along with a gene (Quaking) that has also been implicated in regulating myelin. Our study investigates the abnormal functioning of glial cells (e.g., a loss of myelin structure in the auditory nerve) following noise injury. New knowledge regarding how the Quaking gene and glial cells influence myelin and auditory nerve function is necessary for the development of new therapies for noise-induced hearing loss and other forms of hearing impairment in Veterans.